Universal optical coherence polarimetry

Project Summary
The goal of this research is to enable the integration of advanced polarimetric imaging into existing optical
coherence tomography (OCT) hardware and expedite its clinical translation. OCT is essential in contemporary
ophthalmology and is routinely used to guide percutaneous coronary interventions. Extending OCT to measure
polarization effects arising from tissue anisotropy affords contrast between tissues that are indiscernible in
OCT’s conventional scattering signal. Polarization provides insight into the make-up and physical orientation of
tissue microstructure beyond the spatial resolution of OCT. Intravascular polarimetry with polarization-sensitive
(PS)-OCT offers refined insight into coronary atherosclerosis in patients suffering from myocardial infarction
and other coronary syndromes and may improve patient management and guidance of percutaneous
interventions. In the eye, PS-OCT has shown promise to detect alterations of the retinal nerve fiber layer
(RNFL) that precede the degeneration of its retinal ganglion cell axons encountered in glaucoma, the leading
cause of irreversible blindness. However, the dissemination of PS-OCT relies on adoption by a wider
community, which has been hindered by the excessive hardware complexity of conventional PS-OCT.
This project develops a universal and robust signal processing framework for optical coherence polarimetry
(OCP) that accommodates novel simplified hardware implementations. Coherent measurements of the
polarization response to propagation through tissue conventionally require polarization-diverse detection and
illumination with two input states. To avoid the acute complexity of multiplexing two input states, prototype PS-
OCT systems currently employed for imaging the coronary arteries or the lung use sequential input modulation.
Still, this remains incompatible with the substantial commercial OCT instrument infrastructure available in the
clinic today. OCP capitalizes on an intrinsic symmetry constraint manifesting in round-trip measurements
performed with OCT, which enables the recovery of polarization effects from previously ill-conditioned
configurations and enables adaptation of existing commercial OCT instruments to perform advanced tissue
polarimetry. Aim 1 integrates concepts from magnetic resonance image reconstruction into OCP to
compensate for detrimental system effects and suppress speckle-induced polarization noise. Aim 2 adapts
OCP to commercial clinical intravascular OCT instruments using a single, spectrally varying input state and
polarization diverse detection for investigating plaque rupture and healing in patients. Aim 3 performs OCP with
retinal OCT instruments using a single spectrometer, relying on a rotating waveplate module, fitted into the
accessible round-trip path and repeated scan patterns established for OCT angiography. RNFL birefringence
will be investigated with the adapted clinical instruments in glaucoma patients and healthy controls.
Combined, this work will provide the clinical OCT imaging community with a toolbox of algorithms that
transforms existing OCT instruments with minimal modification into powerful polarimetric imaging platforms.

Public health relevance
Project Narrative This project develops novel imaging capabilities for optical coherence tomography (OCT) systems in the clinic. Analyzing the polarization state of the OCT light may enable earlier detection of glaucoma, which is the leading cause of irreversible blindness. Used for intracoronary imaging after myocardial infarction and coronary syndromes, it may improve patient management and help prevent future adverse coronary events.